Molecular mechanisms of memory maintenance and dysfunction in neural circuits

The cardinal symptom of individuals with Alzheimer’s disease (AD) is progressive loss of long-term memory.
Multiple pathologic mechanisms, including amyloid-b (Ab) plaques and neurofibrillary tangles (NFTs),
contribute to AD. Early memory dysfunction in AD is thought to arise from synaptic dysfunction that progresses
within entorhinal-hippocampal circuits along the trisynaptic pathway. But how AD disrupts information storage
encoded by neuronal networks maintaining long-term memory within these circuits could not be investigated,
because the persistent molecular mechanisms maintaining stability of the networks were unknown.
However, the parent grant R01MH115304 investigates a persistently active atypical PKC (aPKC) isoform,
PKMz, that is a core molecular mechanism for maintaining LTP, long-term memory, and stable entorhinal-
hippocampal network activity dynamics. We discovered that after its initial synthesis, persistent interactions
between PKMz and the human memory- and AD-linked, postsynaptic scaffolding protein, KIBRA, maintain late-
LTP and long-term memory. Compensatory mechanisms substitute for this core mechanism in PKMz-null
mice, when the other aPKC, PKCi/l, becomes persistently active to sustain LTP and store suboptimal
memory. By calcium-imaging, we find that CA1 ensemble activity dynamics express a long-term representation
of spatial memories internally organized as a 2-D manifold. This organization is disturbed by PKMz inhibition,
improves with experience, and crucially constrains memory-related ensemble activity patterns.
Thus, our overall hypothesis is Ab (and in future studies NFTs and neuroinflammation) disrupts core and
suboptimal compensatory aPKC maintenance mechanisms within neuronal ensembles that organize and
encode long-term memories. Supplementary Aim 1 tests whether aPKC dysregulation, in a hierarchy of PKMz-
KIBRA loss and PKCi/l compensation, is a feature of the deficits of LTP maintenance during development of
Ab-producing, amyloid precursor protein/presenilin 1 (APP/PS1) mutant mice. In preliminary data, we observe
decreased PKMz together with increased PKCi/l in CA1 pyramidal cells of aged APP/PS1 mice, suggesting
suboptimal compensation. Supplementary Aim 2 tests whether PKMz downregulates in APP/PS1 mice at
dendritic sites of spatial memory storage, and where entorhinal inputs terminate that express PKMz without
memory-dependent increases, which we hypothesize organize manifold dynamics that are the substrate for
memory formation. In Supplementary Aim 3, we will record CA1 neural activity for weeks by imaging GCaMP6f
in behaving APP/PS1 mice and controls, to measure both memory-task information and the 2-D manifold
dynamics in the patterns of activity. These 3 Supplementary Aims are: 1) within the scope of R01MH115304,
2) will elucidate how AD pathology causally disrupts the fundamental mechanisms of memory maintenance in
neuronal networks, and 3) will stimulate progress by pioneering a strategy for studying the disruption and
potential amelioration of core memory storage mechanisms in circuits affected by AD and related dementias.

Public health relevance
How the molecular mechanisms that persistently modify neuronal networks to maintain long-term memory are disrupted in disorders of memory such as Alzheimer’s disease (AD) is a fundamental question in neurology and neuroscience. Atypical PKCs (aPKC), the persistently active isoforms PKMz and PKCi/l, are core molecules maintaining late-phase synaptic long-term potentiation (LTP) and several forms of long-term memory. In this application for an Alzheimer’s-Focused Administrative Supplement for NIH Grants that are Not Focused on Alzheimer’s Disease, we propose to examine how disruption of the aPKCs contribute to deficits in maintaining the representations of memory in neural circuits, and to lay the groundwork to causally test their roles in the deficits of learning-induced changes in the ensembles of neurons in mouse models of the pathophysiological mechanisms of AD.